Targeting visceral pain through intestinal neuropod cell GUCY2C signaling

Visceral hypersensitivity (VH) and pain in disorders of gut-brain interaction (DGBI), like constipation-type irritable
bowel syndrome (IBS-C) or chronic idiopathic constipation (CIC), afflicts >10% of the population with reducing
quality of life at a cost of ~$30B/y in the U.S. The etiology of VH in DBGI is not known. VH reflects recruitment
of silent dorsal root ganglia (DRG) visceral afferents, reducing their threshold to fire, and increasing their rate of
firing, action potentials. Current analgesics, including non-steroidal anti-inflammatory drugs and opiates, are
inadequate, with poor efficacy and side effects, highlighting the clinical need for novel therapeutics. The intestinal
receptor guanylyl cyclase C (GUCY2C) binds cognate peptides at the extracellular domain that activate an
intracellular catalytic domain, converting GTP to cyclic GMP, the downstream effector. GUCY2C is the receptor
for diarrheagenic bacterial heat-stable enterotoxins (STs), and the homologous hormone uroguanylin in small
intestine and their receptor activation induces secretion (diarrhea for STs). This secretion is the basis for treating
DBGI constipation syndromes with linaclotide (Linzess™), an ST analog, or plecanatide (Trulance™), a
uroguanylin analog. Beyond secretion, GUCY2C agonists relieve pain in DBGI patients and rodents, reducing
visceral nociception produced by colorectal distension (CRD). While visceral pain relief by agonists is mediated
by GUCY2C, mechanisms, and their role in the pathophysiology of VH, are unknown. Interestingly, GUCY2C
agonists are formulated for activity confined to small intestine. Our recent studies revealed that DBGI patients
with VH lose uroguanylin, silencing GUCY2C in small intestine. Additionally, we discovered that GUCY2C is
over-expressed by small intestine neuropod cells, which synapse with DRG neurons controlling gut-spinal
cord signaling. Silencing GUCY2C produced spontaneous VH identical to that produced by inflammation. In
close agreement, neuropod cells produce DRG neuron hyperexcitability which is eliminated by GUCY2C
signaling. These data suggest a novel Anatomical Hypothesis in which neuropod cells in small intestine control
the excitability of DRG neurons afferent to the spinal cord which, in turn, inhibit nociceptive signaling from CRD.
The Pathophysiological Hypothesis suggests that VH in DBGI reflects uroguanylin loss, silencing GUCY2C
in neuropod cells in small intestine, disrupting the control of DRG neuron excitability which amplifies colorectal
nociception. The Therapeutic Hypothesis suggests that GUCY2C-cGMP signaling can be selectively amplified
only in neuropod, but not other intestinal, cells to suppress neuron excitability controlling visceral pain without
producing secretion and diarrhea, the major therapeutic limitation to oral GUCY2C agonists. Proposed studies
will define key elements of a new gut-spinal cord axis in which GUCY2C drives neurotransmission by neuropod
cells in small intestine to regulate neuron excitability controlling visceral pain in the colorectum. The potential to
translate these insights into new therapeutic paradigms for VH targeting neuropod cells to maximize analgesia,
but minimize diarrhea, is highlighted by the availability of oral GUCY2C agonists to treat constipation.

Public health relevance
While chronic visceral pain afflicts about 10% of the population globally, including in the U.S., and produces life-long physical and psychiatric burdens on patients and their families, this syndrome has no known causes and is without satisfactory therapeutic options. This proposal will explore the novel disease mechanism that there is a previously unrecognized link between hormones secreted by the intestine and the development of hypersensitivity of nerves in the gut. The working hypothesis suggests that those hormones can be used as oral drugs to eliminate the hypersensitivity of nerves in the gut, to treat and prevent chronic visceral pain.